JHU-Mayo-NIA Murine Senescence Mapping Program (JMN-MSMP)

The overall goal of the JHU-Mayo-NIA Murine Senescence Mapping Program (JMN-MSMP) is to create an Atlas
of Senescence in Murine Tissues across the lifespan. The proposal encompasses unique and novel biological
and computational resources and strategies to map senescent cells (SnCs) in murine tissues. Biological
resources include aging mouse colonies of multiple strains, including those with reporters for identification of
SnCs. We also have access to a robust murine tissue bank and cataloging infrastructure for aging tissues,
including those with age-related pathology. Computational resources include single-cell sequencing and spatial
transcriptomics expertise, transfer learning algorithms that can identify SnCs and elucidate cell communication
from single-cell datasets, and integration of genomics and multiple imaging modalities to identify SnCs in tissues
in 2D and 3D. For this proposal, the JMN-MSMP team will focus first on developing a timeline of the emergence
of senescence markers in plasma/serum in tissues from the National Institute of Aging murine aging program
including brain. Importantly, we have archived tissues from two genetically distinct strains of laboratory mice of
both sexes over their lifespan that will allow us to implement a rigorous and multidimensional analysis as soon
as the Program is funded. This will be followed by in depth single cell analysis of selected tissues for senescence
mapping. The JMN-MSMP will consist of three Core components: the Administrative Core (AC), Biological
Analysis Core (BAC), and Data Analysis Core (DAC). The Specific Aims of the JMN-MSMP are:
Aim 1. Overall JMN-MSMP Research Strategy: Integrate genomics and imaging strategies to build a
comprehensive Atlas of Senescence in Murine Tissues, and to define the physiological impact of senescent
cells.
Aim 2. Overall JMN-MSMP Management Strategy, Goals, and Milestones: Provide infrastructure to support an
integrated research effort toward creation of the Atlas.
Aim 3. JMN-MSMP Resource Sharing: Ensure that tissues, data, methods, and technologies are available to
other TMCs, and that appropriate data deposition and sharing policies are in place.

Public health relevance
The overall goal of the Johns Hopkins-Mayo-NIA Murine Senescence Mapping Program (JMN- MSMP) is to create an Atlas of Senescence in mouse tissues that coincide with tissues being explored in the human SenNet. The JMN-MSMP team combines expertise in aging, senescence, immunology, single-cell analysis, data sciences, and innovative computational approaches to achieve this goal. We will define cellular and molecular features of senescence, elucidate the heterogeneity of senescent cells, and characterize their impact on other cells and tissues.